Support Mentoring of Early Career Clinical Researchers from Diverse Backgrounds

This application responds to RFA-DK-22012, Investigator Award to Support Mentoring of Early Career
Researchers from Diverse Backgrounds to provide protected effort and resources to Dr. Gallagher, an
established NIDDK-funded investigator and mentor to provide high quality mentoring to graduate students and
postdoctoral fellows from diverse backgrounds and underrepresented groups. Dr. Gallagher has extensive
experience mentoring fellows and junior faculty, including from underrepresented groups. Her leadership role
as MPI in The Physiology of The Weight Reduced State (POWERS) study (5UH3DK128302-03: MPIs Gallagher,
Mayer, Leibel, Rosenbaum) provides a rich environment for training with exposure to a diverse array of measures
and methodologies. It is well known that obesity is a major contributor to human illness and health care costs.
Modest weight loss can mitigate the severity – or entirely reverse - many of these phenotypes. Maintenance of
a 7% reduced body in persons, lean and with obesity invokes homeostatic changes in energy expenditure
(decreased) and hunger (increased) that tend to restore body weight. We hypothesize that the heterogeneity of
response, currently not characterized, accounts for differences in long-term success for reduced weight loss
maintenance. POWERS will prospectively interrogate the physiological/behavioral systems that contribute to
variability in weight change following weight loss. Healthy adults with obesity will be studied before and
immediately after weight loss (Phase 1), and during the follow-up 12 months observational Phase 2. Participants
will be extensively phenotyped at 4 timepoints across the 18 months study: weight, body composition, total
energy expenditure, energy intake, resting energy expenditure, physical activity, exercise efficiency, sleep
quality, food choice, behavioral and psychosocial assessments. POWERS (within the New York Nutrition Obesity
Research Center at Columbia) will serve as the framework through which the proposed K24 mentoring and
training program will be integrated. Mentoring Aim 1-Research: within the framework of POWERS study, to
provide the trainee with exposures and training in the conduct of clinical research involving advanced state-of-
the art methods, training in rigor and reproducibility in research, human subject compliance, and scientific
manuscript and grant writing; Mentoring Aim 2-Career Development: attend and give research presentations at
local and national meeting (eg, ObesityWeek sponsored by The Obesity Society); attendance of seminars for
exposure to current research on methodological, biological, psychological, and nutritional aspects of obesity,
networking with experts in the related fields, career development, guidance on how to effectively collaborate with
researchers from diverse backgrounds and disciplines. My primary training aim as a mentor is to develop skills
to be a more culturally aware mentor to optimally mentor early career investigators from diverse backgrounds.
With enhanced research and leadership skills, manuscript and grant writing experience, and an established
mentoring network, trainees will be well positioned to grow and be successful in their careers..

Public health relevance
The regulation of body weight - and the impact of excess weight on clinical phenotypes such as diabetes, cardiovascular disease and cancer - is extremely complex necessitating special training in centers with broad basic and translational research portfolios for the scientists who will help to break this nexus of disease. This K26 is to support mentoring of early career investigators from underrepresented and diverse backgrounds through providing protected effort and resources to Dr. Gallagher who will deliver focused mentoring, academic course work, sophisticated research experiences, and career development and networking, enabling them to transition to research independence. This program has important national implications by virtue of adding to a critical group of diverse bioscientists.